Alveolar Epithelial Cell Dysfunction Induced By Flavored E-Cigarette Aerosols

Abstract
E-cigarette devices produce an aerosol from e-liquids containing flavorings, nicotine, and vehicle. Inhaled e-
cigarette aerosol can reach the alveolar region. Alveolar type II (ATII) cells produce and secrete pulmonary
surfactant, which decreases surface tension. They also have a stem cell potential, proliferate and repair the
epithelium after damage leading to lung regeneration. Due to their energy-demanding functions and location in
the lung, they depend highly on mitochondria. Mitochondrial DNA lacks histones that serve as a barrier against
damaging factors, contributing to its susceptibility to damage. Mitochondrial dysfunction can lead to mitophagy
and ATII cell death. Our preliminary results in the parent R01 grant and this application demonstrate the harmful
effect of e-cigarette aerosols with fruit and dessert flavors on human primary ATII cells. The goal of this
administrative supplement proposal is to clarify further the sex influences on human primary ATII cell dysfunction
caused by exposure to flavored constituents and e-cigarette aerosols. In Aim 1, we will compare DNA damage
in ATII cells exposed to flavored constituents and e-cigarette aerosols with fruit and dessert flavors. In Aim 2, we
will define the impact of this exposure on mitochondrial function in ATII cells. Obtained results will define sex
influences on the respiratory injury risk of flavored constituents and e-cigarette aerosols.

Public health relevance
Narrative The use of e-cigarettes is increasing, and the presence of fruit and dessert flavors in e-liquid is attracting people to begin using them. We will study the effect of sex influences on the impact of flavored constituents and e- cigarette aerosols in alveolar epithelial cells. This approach will allow comparing the susceptibility of males and females to lung injury.